Regulatory Science in Environmental Health and Toxicology

PROJECT DESCRIPTION
Regulatory Science in Environmental Health and Toxicology
This proposal is to continue the T32 program in “Regulatory Science in Environmental Health and Toxicology”
at Texas A&M University. Funds are requested to support eight pre-doctoral (Ph.D. candidates) and two post-
doctoral trainees in the existing highly integrated degree-granting Interdisciplinary Faculty of Toxicology
program. Our goal remains to prepare trainees to function as independent researchers and/or practitioners in a
multidisciplinary setting, by providing training in mechanistic research and risk assessment with a focus on
scientifically sound, risk-based regulatory evaluations of the effects of drugs and other chemicals on human
health and the environment. To achieve this goal, didactic and research experiences are offered by a team of
20 outstanding investigators who specialize in mechanistic toxicology, community engagement, exposure
assessment/environmental chemistry, public policy, epidemiology, biomedical engineering, and data science
and modeling. Recruitment is conducted through traditional external advertisement and professional societies,
as well as from a number of existing Texas A&M programs that offer research experience for undergraduates,
and public health and toxicology masters-level traineeship. Pre-doctoral trainees undertake two laboratory
rotations in their first year in the program and follow a structured core academic curriculum that includes basic
and advanced toxicology, histopathology, pharmacology, biostatistics and research ethics, combined with
courses in risk assessment and exposure assessment. In the second year, additional specialized training is
offered through elective courses that further prepare trainees for careers in research and/or public health
practice. Distinctive features of the program are (i) a strongly encouraged hands-on summer externship through
a broad and diverse network of state and federal governmental regulatory agencies, companis and non-
governmental organizations; and (ii) a series of special programs in the form of boot camps and special
workshops on a wide range of trainee-selected topics (scientific writing, presentation, interview skills, disaster
research and data science). Following the first two years, trainee support for both pre- and post-doctoral fellows
shifts to their mentor’s or independent funding. All mentors have strong records of competitive support from
Federal, State and other sources and this group of mentors is exceptionally well balanced with respect to relevant
scientific expertise, sex and academic career level. Graduates from the program are highly successful in
academia, and sought-after by employers in the industry, governmental agencies and other professional settings.
Our trainees improve public health protection through innovative and rigorous mechanistic research and risk
assessment practice in support of rigorous scientific evidence-based regulatory decision-making.

Public health relevance
PUBLIC RELEVANCE STATEMENT This training program builds on a long-standing and successful history of training scientists for careers in toxicology and environmental health at Texas A&M University. We aim to keep our training and research base strong and also provide unique focus on regulatory science, a scientific discipline consisting of the development and application of scientific methods, tools, and approaches that are used to support regulatory and other policy objectives. As the fields of toxicology and environmental health acquire new tools to better detect and characterize human health hazards, our trainees receive a strong, broad background in basic science with opportunities to specialize in research and/or decision-making for protection of public health and the environment.